Optimizing Engagement in Services for First-Episode Psychosis (FEP) in the Community Mental Health Setting

Disengagement from services is a major public health problem for individuals with first-episode psychosis
(FEP) as up to 40% of individuals prematurely terminate early care. Individuals with FEP are consequently at
increased risk of persistent symptomatic and functional impairment and poor long-term outcomes. Engagement
can be improved by (1) identifying pragmatic and effective evidence-based interventions, (2) pinpointing the
mechanisms through which change in engagement is achieved, and (3) enhancing the literature on
engagement, such as by developing a nuanced and dynamic conceptualization of engagement to guide future
research. In the U.S., effective interventions for engagement are particularly needed for community mental
health services, which deliver most mental health care and encounter major engagement issues, and for hard-
to-reach communities, such as those comprised by Latinos. Research conducted with individuals with
psychosis has shown that Behavioral Activation (BA), designed for the treatment of depression, may effectively
target engagement and also symptomatic and functional outcomes. This study will develop 12-session BA for
FEP and compare it to treatment-as-usual over six months with a sample of 58 (29 per condition) Latinos and
their family caregivers in a longitudinal randomized controlled trial. Dyads will also participate in comparable
family support groups delivered separately by condition. To examine mechanisms of change, the association
between intervention mediators and engagement will be examined to determine whether changes in mediators
precede changes in engagement over time. Using mixed-methods, the relationship between local/cultural
factors and engagement will be explored. Qualitative methods will be used to explore how local/cultural factors
impact engagement for future quantitative analysis, how specific characteristics of robust predictors (e.g.,
family support) influence engagement, discover other critical influences, consider BA specific factors, and
generate a model of engagement in FEP care with attention to stages of development, illness, and treatment.
The project provides training in service engagement and intervention for FEP, developing and applying BA for
FEP, addressing engagement during FEP in hard-to-reach communities with cultural responsivity, and relevant
research methods with primary mentor, Alex Kopelowicz, M.D, co-mentors Steven R. Lopez, Ph.D., Lisa B.
Dixon, M.D., M.P.H., and Sona Dimidjian, Ph.D., and consultants Hilary Mairs, Ph.D., Anahi Collado, Ph.D.,
Mark Lai, Ph.D., Jodie Ullman, Ph.D., Lawrence Palinkas, Ph.D., and Ethel Nicdao, Ph.D. Activities will be
sustained through regular communication with and between trainers and resources at California State
University San Bernardino, University of Southern California, and relevant institutions/sites. Training supports
Dr. Santos’s long-term goal of advancing the field of service engagement for persons with FEP from hard-to-
reach communities. The project will enhance the FEP engagement and intervention field and supports the
NIMH’s goals of improving engagement and maximizing recovery for persons with early psychotic illness.

Public health relevance
8. PROJECT NARRATIVE Psychosis prevents individuals from meeting their basic needs and leading meaningful lives and early intervention mitigates its effects, but services are often undermined by problems of engagement. The objective of this proposal is to advance the literature on effective pragmatic interventions for engagement, processes that lead to successful engagement, and the nature of engagement with services across time and contexts with a focus on individuals with FEP from hard-to-reach communities. Findings may help improve individuals’ engagement with public mental health services during the early stages of psychotic illness across the U.S.